Integrating genome-wide association study data with single-cell `omics' to reveal the cellular effectors of glioblastoma predisposition

ABSTRACT
Glioblastoma (GBM) is the most common primary malignant brain tumor in adults and remains uniformly lethal,
with median survival <15 months despite intensive therapy. High-dose ionizing radiation remains the only
confirmed environmental risk factor, but the first stages of tumor initiation appear to occur decades prior to clinical
diagnosis. Although the etiology of GBM remains poorly understood, genome-wide association studies (GWAS)
have identified seventeen independent risk alleles associated with heritable predisposition. These alleles are
non-coding regulatory variants, and their impact on disease risk reflects the varied gene expression patterns and
epigenetic programs of the underlying cell types and states involved in tumor initiation and maintenance. We
recently performed stratified Linkage Disequilibrium Score Regression (SLDSR) analysis to partition the
heritability of GBM across tissue types, observing significant enrichment in deep gray matter structures of the
brain and in lymphocytes at the interface of innate and adaptive immunity. However, SLDSR is limited by the
underlying reference datasets employed. We hypothesize that a subset of cell states/types comprising the tumor,
the tumor microenvironment, and the developing brain will be enriched for GBM heritability, reflecting their critical
roles in cellular transformation and tumor establishment. Our OVERALL GOAL is to incorporate single-cell
transcriptomic and epigenomic datasets into an improved platform for partitioning GBM heritability at
unprecedented resolution, revealing both early neurodevelopmental and late pathologic cell types that serve as
effectors of GBM predisposition. This collaborative project will leverage a wealth of existing data resources to
test our hypothesis through three complementary aims. In Aim 1, we will partition the genetic heritability of GBM
across meta-modules of malignant cell states and microenvironmental cell types generated from harmonized
snRNA-seq and snATAC-seq datasets in order to identify the cell populations through which genetic
predisposition precipitates GBM formation. In Aim 2, we will overcome the lack of ancestral diversity in GBM
profiling data by performing multiome snRNA-seq and snATAC-seq of GBM cells from 24 African American
patients, evaluate the impact of ancestry on meta-module construction, and partition GBM heritability across cell
states/types. In Aim 3, we will use existing snRNA-seq and snATAC-seq datasets from fetal brain tissues to
partition GBM heritability across early cell lineages in order to examine the neurodevelopmental origins of GBM.
Novel cell states and tumor cell subpopulations enriched for GBM heritability in these aims will be further
characterized and validated using spatially-resolved, in situ RNA sequencing of patient tumors. Despite
extensive molecular and epidemiologic research, the origin of GBM remains poorly defined. This proposal
represents an innovative approach for integrating existing GWAS and single-cell datasets to reveal potentially
unanticipated cell populations involved in GBM formation. Such cell populations may serve as targets for GBM
interception or for the development of more effectively targeted therapies.

Public health relevance
PROJECT NARRATIVE Prior research has revealed a strong role for inherited genetic factors in the development of glioblastoma, an aggressive brain cancer comprised of many distinct and interacting cell types. Although inherited genetic variants are equally present in every cell of the body, the overall goal of this proposal is to understand which specific cell populations are responsible for converting genetic predisposition into tumor establishment. Such insights can help to reveal the origins of glioblastoma and identify unique cell populations that should be targeted for cancer prevention and therapy.